The Farm Effect and Asthma Risk: Determining the Multi-Omic Immune Cell Landscape in Amish and Hutterite Children

PROJECT SUMMARY/ABSTRACT
While exposure to a traditional farm environment has been robustly demonstrated to reduce the risk of childhood
asthma, and immune cells are key drivers of asthma pathogenesis, the mechanisms by which the farm environ-
ment affects immune cells is not well characterized. This proposal focuses on children from two unique U.S.
farming populations, the Amish, who have extensive early life exposure to barn animals and a low prevalence of
asthma, and the Hutterites, who live on industrialized farms without early life exposure to barn animals and their
microbes and have over 4-fold higher prevalence of asthma compared with the Amish. While prior studies have
indicated that both innate and adaptive immune cells differ between Amish and Hutterite children, suggesting
that farm exposures may perturb the immune system early in life, these were limited to focusing on specific
subsets of immune cells. The current proposal seeks to leverage the natural environments of Amish and Hutterite
children and to generate multi-omics datasets to characterize the immune cells in these two populations, thereby
discovering novel immune cells and states in the Amish that are associated with protection from asthma. Aim 1a
will define the transcriptional landscape of Amish and Hutterite peripheral immune cells using single cell RNA
sequencing to annotate distinct cell populations and ask: i) What are the proportions of immune cell types thus
identified? ii) Do these proportions differ in Amish and Hutterite children? iii) What genes differ between Amish
and Hutterite within each annotated immune cell type? Aim 1b will complement and extend Aim 1a by measuring
open chromatin using single nucleus assay for transposase-accessible chromatin sequencing in the same cells
used in Aim 1a so as to delineate the regulatory chromatin underpinning gene expression and ask: i) What
genomic regions demonstrate differential chromatin accessibility (DCA) in the major immune cell populations
between high and low risk environments? ii) Are differentially expressed genes in Aim 1a in regions with DCA?
iii) Which transcription factor binding motifs are enriched in DCA regions in high and low risk environments? Aim
2 will focus on genes at childhood-onset asthma-associated genomic loci and address: i) What cell types are
enriched for expression of genes at childhood-onset asthma loci? ii) What regions of the genome and in which
immune cells are there DCA regions between high and low risk environments that overlap with childhood-onset
asthma loci? This contribution will determine the transcriptional and chromatin states of immune cells in two
unique sets of children with different risk of asthma due to environmental exposures and will provide substantial
clues about asthma risk. Insights from these studies will generate subsequent hypotheses that can then be
empirically tested using functional studies of blood immune cells and will be the basis for subsequent R01 grant
application(s), thereby paving a pathway from mentored to independent investigation. Achieving these goals will
lead to the discovery of new mechanisms of immune regulation in asthma, ultimately leading to novel treatments
for asthma.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because asthma is the most common chronic respiratory illness and the most common chronic childhood illness, and understanding the mechanisms by which early life exposure to traditional farm environments perturbs immune cells will improve the fundamental understanding of asthma biology. This project is relevant to the NIH mission because it seeks knowledge about asthma with a goal of enhancing health, lengthening life, and reducing illness and disability.